The Role of Non-Vesicular Lipid Transport at ER-PM Contact Sites in Phosphoinositide Signaling in Early Dendrite Development

Abstract
Phosphoinositide lipid signaling is implicated in many cellular functions and is crucial in embryonic neuronal development.
PI(4,5)P2 is a key lipid at the plasma membrane (PM), mediating various signaling pathways downstream of secreted cues,
directly downstream of PI(4,5)P2 or following its phosphorylation to PI(3,4,5)P3 (PIP3) by PI3-Kinase. PIP3 and Akt
signaling are critically implicated in dendrite development, effects largely mediated via diffusible neurotrophins.
Neurotrophins BDNF and NT-3 expression are elevated in dendrites during and play a critical role in dendrite growth and
branching. PI(4,5)P2 homeostasis during receptor stimulation is maintained by a cyclical metabolic pathway, phospha-
tidylinositol (PI) cycle. The PI cycle and the enzymatic machinery required to sustain it are spatially segregated between
the ER and PM. In the developing brain, neurons are perpetually exposed to cues that trigger the use and hydrolysis of PM
PI(4,5)P2. Developing neurons must accommodate rapid on-demand PI availability at targeted locations of PI(4,5)P2
signaling and turnover in response to external cues, during extensive morphogenesis in dendrite development. The slow and
non-specific vesicular transport might not meet this demand. Recent evidence suggests that an alternative mode of lipid
transport, by lipid transport proteins at ER-PM contact sites, may provide a localized, rapid on-demand replenishment of
PM PI(4,5)P2 and drive its downstream signaling following its hydrolysis in response to external cues. ER is ubiquitously
present in dendrites of early developing neurons. Thus, PM PI(4,5)P2 replenishment at ER-PM contacts might be prominent
during extensive morphogenesis in embryonic dendrite development. This study determines whether the lipid transport
protein Nir2 is a critical regulator of PI(4,5)P2/PIP3 homeostasis at ER-PM contact sites, and in PI(4,5)P2/PIP3 signaling in
dendrite development. The Phosphatidylinositol Transfer Protein (PITP), Nir2, can provide precursors of PI(4,5)P2 to PM
while also extracting PI(4,5)P2 metabolite PA from PM for PI synthesis in the ER, thus autonomously sustaining the PI
cycle at localized regions of PI(4,5)P2 depletion. Furthermore, Nir2 is recruited to PM only following PI(4,5)P2 hydrolysis.
This makes Nir2 an optimal candidate to accommodate rapid on-demand PI availability at targeted locations of PI(4,5)P2
signaling and turnover in response to external cues, in dendrite development. Using state-of-the-art genetic probes to track
PI(4,5)P2 and PIP3 signaling, combined with cutting edge genetic approaches including acute gene overexpression and
knockdown in utero, CRISPR-mediated genome editing, and highly localized manipulations of signaling, this study is
designed to determine the role of Nir2-activity in dendrite development in mouse developing cortical pyramidal neurons.
The elaborate dendritic arbors of pyramidal neurons underlie synaptic connectivity. Disruption in dendrite development
plays a causative role in many neurodevelopmental and psychiatric disorders, mental disability, epilepsy, Schizophrenia,
Fragile X, and autism. Abnormal activity of Akt is associated with these pathologies and characterized by defects in dendrite
development. Furthermore, Nir proteins are linked to human neuropathologies. By exploring the mechanistic basis of PI-
signaling, this study will advance understanding of early molecular events in dendrite structural plasticity in principal
neurons in the rodent brain and their implications in neurodevelopmental pathologies.

Public health relevance
Significance of the proposed research During early embryonic brain and circuit development, development of a single neuron begins with the establishment of axon/dendrite identities, an architecture that is critical for the directed flow of information in the brain. Aberrations affecting dendrite development lead to developmental neuropathologies, intellectual and motor disabilities, epilepsy, neuropsychiatric, and autism spectrum disorders. Using state-of-the-art molecular probes, cutting edge genetic manipulations, CRISPR-Cas9-mediated genome editing in single pyramidal neurons in vivo, this study is designed to explore the mechanistic basis of phosphoinositide lipid signaling in dendrite development in pyramidal neurons in the developing mouse embryonic brain and contribute to the identification of therapeutic targets for developmental neuropathologies resulting from abnormal dendrite development.